Molecular Epidemiology Studies of Occupational and Environmental Exposures

Ongoing and planned studies include evaluation of populations exposed to benzene, chlorinated solvents, organochlorines, disinfection byproducts. polycyclic aromatic hydrocarbons, arsenic, formaldehyde, diesel exhaust, coal combustion products, and selected pesticides. On-going case-control studies of stomach, esophagus, brain, bladder, renal cell, thyroid, prostate and breast cancer, NHL, and benzene-induced hematotoxicity and hematologic malignancies and cohort studies of women in China and agricultural workers in the United States are evaluating a range of potential genetic risk factors and their interaction with occupational and environmental exposures. Many of these studies are also collecting tumor samples for future molecular analyses.